Building a Sedation Minimization Culture

PROJECT SUMMARY/ABSTRACT
For many years, sedation has been integral to managing patients receiving ventilatory support in the intensive
care unit (ICU). However, patients who are deeply sedated in the ICU suffer from increased immobilization,
delirium, post-traumatic stress disorder, and death. The 2018 Clinical Practice Guidelines for the Prevention
and Management of Pain, Agitation/Sedation, Delirium, Immobility, and Sleep Disruption in Adult ICU Patients
recommend against the routine use of deep sedation, and the Society of Critical Care Medicine has
implemented nationwide campaigns to disseminate evidence-based sedation minimization strategy, the
Spontaneous Awakening Trial. Yet, more than 50% of patients who receive mechanical ventilation are being
deeply sedated worldwide, and only 20-40% of ICUs regularly practice SAT. Interprofessional teamwork is key
to SAT implementation, but optimal strategies to enhance interprofessional team performance around sedation
minimization remain unknown. The objectives of this project are 1) to understand how individual ICU staff
characteristics and their shared assumptions, values, and beliefs shape their collective approaches to sedation
and 2) to promote sedation minimization in the ICU by optimizing the team performance around SAT.
This K23 proposal builds on Dr. Fuchita’s preliminary work at the University of Colorado, which reduced deep
sedation by promoting a sedation minimization culture. Dr. Fuchita seeks to apply rigorous science to
understand the mechanisms of change and develop tools, processes, and strategies that are effective,
implementable, scalable, and sustainable across diverse ICU settings. Aim 1 will identify individual ICU staff
characteristics associated with intentions to minimize sedation using the Sedation Culture survey. Aim 2 will
explore how culture influences interprofessional team dynamics, communications, and collaboration around
SAT using qualitative methods. Aim 3 will use Implementation Mapping to develop and pilot PROMISE-ICU
(PROmoting MInimal SEdatIon CUlture), a program of multifaceted implementation strategies to improve the
adoption and fidelity of SAT at a single ICU and evaluate its acceptability, appropriateness, and feasibility.
Dr. Fuchita’s long-term career goal is to catalyze a fundamental culture change in ICUs worldwide to liberate
patients receiving mechanical ventilation from unnecessary deep sedation. Dr. Fuchita has co-designed
comprehensive career development plans with excellent mentors and advisors to provide him with advanced
training in survey and qualitative research, the science of organizational behavior, implementation science, and
hybrid effectiveness-implementation trials. The University of Colorado is nationally recognized for its
excellence in interdisciplinary health services research, and Dr. Fuchita has unparalleled institutional support
and resources to achieve the proposed research, training, and career development objectives. This K23 Award
will support Dr. Fuchita’s path toward independence by providing him with the unique skills necessary to
design, implement, and evaluate novel interventions to solve complex real-world problems in the ICU.

Public health relevance
PROJECT NARRATIVE Deep sedation of patients receiving mechanical ventilation in the intensive care unit (ICU) continues to be a common practice nationwide despite decades of research demonstrating its harm. This proposal seeks to develop a program of multifaceted implementation strategies (PROMISE-ICU) to increase the adoption and fidelity of Spontaneous Awakening Trials, focusing on interprofessional team dynamics, communications, and collaboration. We will conduct survey and qualitative research to characterize determinants of individual and group behaviors around Spontaneous Awakening Trials and use rigorous implementation science approaches to develop and pilot test PROMISE-ICU to reduce unnecessary deep sedation in the ICU.